Common Inflammation Pathways between Aging and Hypertension That Weaken Bone

Project Summary / Abstract
Osteoporosis is under diagnosed and under treated. It is essential that we develop novel tools for early detection
and treatment strategies to reduce the number of fragility fractures that accompany aging. Systemic hypertension
is another disease of aging that commonly co-exists with osteoporosis and likely predisposes individuals to the
disease. In this multidisciplinary project, we will investigate a common molecular basis between hypertension
and osteoporosis that weakens bone during aging. Our preliminary data indicate that experimental hypertension
involving mice is associated with a striking loss in bone strength, which is mediated in part by the production of
colony stimulating factor 1 (CSF1) in the bone marrow. The first goal of the project will be to test the hypothesis
that enhanced endothelial cell deformation and elevated blood pressure promote the age-related decline in bone
strength. We will employ cell culture experiments in which endothelial cells are dynamically stretched below
human monocytes with and without exogenous recombinant proteins to determine if factors released by the
activated endothelium promote osteoclast differentiation. In addition, we will lower blood pressure of aged mice
and determine if this improves bone strength by reducing inflammatory cytokines that favor bone resorption. The
second goal will be to test the hypothesis that enhanced sympathetic tone in aging and hypertension promotes
immune activation and bone loss. We are experts at modulating sympathetic tone using a technique called
Designer Receptor Exclusively Activated by Designer Drugs and by local denervation techniques. Thus, we will
increase sympathetic tone to determine if this mimics the age-related decline in bone strength and decrease
sympathetic tone to determine if this prevents hypertension and aging-induced loss in bone strength. The third
goal will be to delete the endothelial CSF1 gene in adult mice to firmly establish the endothelium as a mediator
of osteoporosis. Finally, our prior work has established a critical role of the cytokine interleukin (IL) 17A in
hypertension, and others have shown that it plays a critical role in bone loss due estrogen withdrawal
(menopause). We will therefore generate mutant mice that will allow deletion of IL17 receptor A in adult mice
and determine if this prevents hypertension-related bone loss. As a translational goal, we will treat aged or
hypertensive mice with a control antibody and vehicle, a neutralizing anti-CSF1 antibody, or an IL-17RA
antagonist and determine if these strategies improve bone strength. In all aims we will 1) monitor blood pressure
and bone mass, 2) assess immune cell profiles in the bone marrow, and 3) comprehensively characterize bone
strength including toughness and other bone quality measurements. By understanding how hypertension affects
bone marrow in the context of aging and by working as a collaborative research team comprised of different skill
sets, new therapeutic strategies can be identified to prevent the age-related increase in fracture risk.

Public health relevance
Project Narrative Osteoporosis and hypertension are major health concerns that lower lifespan and hinder the ability to remain independent and active as people age. This project will investigate pathways by which hypertension and aging activates the bone marrow to cause bone loss and weaken bone. By using established pre-clinical models of this disease and aging, the collaborative team with different but complementary expertise is well positioned to identify a new and translatable strategy for the prevention of fragility fractures.